Combining Machine Learning Methods and Scalable In Vivo Biomarkers for the Early and Accurate Detection of Alzheimer's Disease in Veterans

Veterans are aging more rapidly than the US population, leading to greater numbers of Veterans with
Alzheimer’s disease (AD) and related disorders (ADRD). Improved detection of AD pathology will provide
Veterans with earlier access to services and initiation of treatment. Early and accurate detection of AD is
critical for cost savings and effective treatment. However, current in vivo biomarkers for AD pathology require
procedures not generally available such as amyloid positron emission tomography (aPET) or lumbar puncture.
This project has the potential to provide Veterans across the country with a convenient and cost-effective tool
to detect AD pathology, ideally before the disease has resulted in significant degeneration. This proposal aims
to enhance the detection of ADRD with machine learning applied to results from a routine clinical
neuropsychological battery and digital phenotyping of the clock drawing test (CDT). Machine learning and
digital phenotyping show promise as scalable means to detect ADRD, but few studies have used methods with
non-proprietary technologies and none have used Veteran samples. Traditional machine learning models will
be computed to detect aPET positivity using archival data from a single VA medical center. [Record review will
be completed on approximately 550 Veterans with aPET imaging followed by the VA Boston Memory
Disorders Clinic between January 2015 and April 2023. Next, the project will examine high-dimensional but
scalable digital phenotyping of a video CDT. A sample of approximately 450 Veterans with aPET imaging will
be collected from the VA Boston Memory Disorders Clinic.] This project will assess deep learning classifiers
derived from video recording of the clock drawing process. These classifiers will be assessed as standalone
predictors of aPET positivity and in ensemble models with other clinical neuropsychological predictors. In
addition, a sample of approximately 1000 Veterans with available clinical data will be collected from the VA
Boston Memory Disorders Clinic. The project will examine whether clock drawing classifiers can be fine-tuned
to detect AD as a suspected etiology, based on clinical diagnostic impression from the comprehensive
neurological evaluation. This trained model will be externally validated in a prospective sample of 400 Veterans
recruited from the National TeleMental Health Center (NTMHC) Memory Disorders service, which provides
care for Veterans from over 25 VA healthcare systems. Finally, clock drawing classifiers will be fine-tuned to
detect the presence of cognitive impairment in the same training and external validation cohorts. It is expected
that machine learning algorithms will classify aPET positivity with modest accuracy using clinically available
neuropsychological tests consisting of several hundred data points. However, it is expected that deep learning
algorithms applied to thousands of images from the clock drawing process will produce excellent classification
accuracy for all clinical outcomes across samples. This project could result in an accurate and scalable tool to
detect AD pathology at an early stage and inform the need for confirmatory aPET imaging or lumbar puncture.
The research and career development activities proposed will prepare Dr. Frank for his long-term goal of a
research career in phenotyping of neurodegenerative conditions in Veterans. He proposes focused
coursework, directed study, and mentoring from a group of well-established investigators who are leaders in
their respective fields, as well as practical research experience completing the project proposed. The proposed
training plan focuses on the following objectives: (1) training in traditional machine learning model development
and validation, (2) training in cognitive neuroscience and the neuropathology of Alzheimer’s disease, (3)
training in software pipeline creation to process and manage high-dimensional data, (4) training in deep
learning methodologies applied to image analysis, and (5) training in VA culture related to ethical research and
translational clinical science. The knowledge, techniques, and experience gained through this proposal will
allow Dr. Frank to successfully compete for a Merit Review Award and become an independent investigator.

Public health relevance
Early and accurate detection of Alzheimer’s disease (AD) is critically important for Veterans. This proposal examines whether machine learning can be applied to results from a routine neuropsychological battery to detect findings from amyloid positron emission tomography (aPET), a standard biomarker for AD pathology. Then, we examine whether machine learning classifiers derived from clock drawing videos will detect the same outcome, alone and in combination with other predictors. We also examine whether clock drawing classifiers will detect AD as a suspected etiology based on clinical diagnostic impression. Finally, we examine whether clock drawing classifiers will detect the presence of cognitive impairment on objective neuropsychological tests. We expect acceptable to excellent accuracy for all clinical outcomes, particularly when clinical neuropsychological data are used in combination with clock drawing classifiers. This project could provide a convenient and cost-effective means to detect AD pathology in Veterans.